Managing metabolic disruption in pancreatic cancer to prevent weight loss and improve quality of life

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDAC) is the fourth-leading cause of cancer death in the United States, with
60 000 cases diagnosed annually and five-year survival rate of only 10%. It is projected to become the second-
leading cause of cancer-related mortality by 2030. PDAC is also associated with poor quality of life (QOL),
including cachexia, in approximately 80% of patients. Cachexia is a contributing cause to 30% of deaths in PDAC
and has no approved pharmacologic treatment. PDAC is also strongly associated with hyperglycemia. Half of
patients have diabetes at the time of diagnosis and 80% experience hyperglycemia during treatment; the
association is likely bi-directional, meaning that there is both evidence that diabetes causes PDAC and that
PDAC causes diabetes. As a result, many patients with PDAC must use antidiabetic drugs such as metformin,
sulfonylureas, or insulin. Hyperglycemia management during PDAC is an important aspect of supportive care
with direct implications for QOL. Comparative effectiveness research on hyperglycemia management in PDAC
is almost certain to improve supportive care by identifying which drugs best balance glucose control, side effects,
and maintenance of healthy weight. This need for evidence in this specific population is especially pressing
because the usual hierarchy of diabetes drugs may be inverted in PDAC patients. For example, prescribers
deprecate sulfonylureas in routine diabetes practice in part because they promote weight gain, but that property
could make them especially useful in patients with PDAC. Very little research has been done comparing
sulfonylureas to metformin (the most widely used antidiabetic drug) or other alternatives as a supportive care
intervention in PDAC. This proposal aims to close this evidence gap by, in Aim 1, conducting a retrospective
cohort study testing the hypothesis that, compared to metformin, sulfonylureas are associated with better weight
maintenance in patients with PDAC, and in Aim 2, enrolling 40 patients with hyperglycemia undergoing systemic
treatment for PDAC in a trial assessing the safety of glipizide, a sulfonylurea, with respect to the key safety
outcome of rate of hypoglycemia and the key effectiveness outcome of reducing blood glucose levels. This
project will lay the groundwork for phase 3 clinical trials to determine whether choice of antidiabetic drug can
improve QOL and even overall survival in patients with PDAC.

Public health relevance
NARRATIVE Pancreatic ductal adenocarcinoma (PDAC) is the fourth-leading cause of cancer death in the United States, with 60 000 cases diagnosed annually and five-year survival rate of only 10%; patients with PDAC very commonly develop diabetes (high blood sugar) and rapid weight loss. Some drugs that can be used to treat diabetes in PDAC, notably sulfonylureas, may be particularly effective in controlling blood sugar and preventing weight loss; however, sulfonylureas can also cause dangerously low blood sugar. We will compare sulfonylureas to the most commonly used drug for diabetes—metformin—to assess whether sulfonylureas can safely be used to control blood sugar levels and prevent weight loss in patients with PDAC.